In vivo Screening Methods Targeting Levels of Tau Protein within Mouse Brains

PROJECT SUMMARY/ABSTRACT
Neurodegenerative diseases are devastating, fatal diseases that affect millions of people worldwide and
have no definitive treatment. A well-known neurodegenerative disease, Alzheimer's Disease (AD), is the third
most common leading cause of death, with the AD Association in 2022 reporting more than 6 million people
affected in US. Although there are no clear underlying mechanisms of pathogenesis, accumulation of toxic
protein species, such as tau protein in AD, drives a large and diverse group of neurodegenerative diseases, both
genetic and sporadic. Modulating levels of disease-driving proteins has improved disease phenotypes,
highlighting a promising strategy for therapeutic development. Large-scale cell-based genetic perturbation
screens are canonical and critical tools used to find essential protein regulators that control levels of disease-
driving proteins. However, since these 2D models consist of actively dividing cells with vastly different properties
that lack physiological authenticity compared to in vivo cells, important brain-specific regulators are not present
and thus not detected and false positives are more likely to be detected. This results in an inefficient process
requiring multiple rounds of labor-intensive in vitro assays followed by validation using in vivo models before
animal studies can be performed that will hopefully lead to valid therapeutic targets.
The goal of this proposal is to bypass cell-based screens by developing a feasible and high-
throughput genome-wide in vivo CRISPR/Cas9 screening method (Aim 1). Furthermore, to enhance
translation and as a means of validation, this method will be used to find regulators of tau protein levels
in the mouse brain (Aim 2). Aim 1 will set the parameters for in vivo screening using intracerebroventricular
(ICV) injection of the adeno-associated virus (AAV) harboring gRNA/Cas9 into neonatal mice to broadly perturb
target genes in the brain. Fluorescence activated cell sorting (FACS) analysis will then be utilized to track protein
levels in each dissociated single cell in a high throughput manner. Aim 2 will expand the in vivo screening method
into a tauopathy mouse model, which recapitulates AD-related phenotypes and involves the pathogenic
accumulation of tau protein in two brain regions (cerebral cortex and striatum) vulnerable to neurodegeneration.
The impact of this proposal is manifold: providing a powerful tool to bypass labor-intensive in vitro processes for
the identification of new therapeutic targets for numerous neurodegenerative diseases; providing comprehensive
insight into the regulation of tau and reveal candidate therapeutic targets for tauopathies; enhancing our
understanding of how disease-causing proteins are differently regulated depending on the brain region, in normal
physiological conditions versus disease condition, which will provide insight into regional vulnerability/resilience
to neurodegeneration. Taken together, completion of this endeavor will provide a novel and powerful tool
to understand the regulation of disease-driving proteins and will help us discover promising therapeutic
targets that are validated in the brain, making the strategy applicable to many neurological diseases.

Public health relevance
PROJECT NARRATIVE Numerous neurodevelopmental and neurodegenerative disorders are driven by aberrant levels of proteins that must remain tightly regulated for brain health, such as tau aggregation in Alzheimer’s disease. Large-scale cell- based screens have been used to discover previously unknown regulators of highly regulated proteins, however these screens require multiple rounds of strenuous validations to eventually identify the candidate that will then need to be tested in vivo. Here, this project will bypass cell-based screens by developing a high-throughput genome-wide in vivo CRISPR/Cas9 screening method, which will provide a powerful and efficient tool to identify new therapeutic targets for several neurological disorders driven by altered protein levels.